Improving retention along the hypertension care cascade and reducing cardiovascular risk among people with HIV who use a safety net clinic

ABSTRACT
Hypertension (HTN) is among the strongest risk factors for cardiovascular disease and myocardial infarction, but only one-third of people with HIV (PWH) who receive care at a safety net clinic achieve hypertension control. People with severe financial challenges, particularly those with unmet subsistence needs like unstable housing and food insecurity, have higher rates of HTN and cardiovascular events in this setting. However, we still cannot pinpoint exactly how unmet subsistence needs influence where or why patients drop off the HTN care cascade. Here we propose a study among safety net HIV clinic patients. It uses an explanatory sequential design that includes quantitative survey data and qualitative contextual information. Our goal is to understand each stage of the HTN care cascade (diagnosis, treatment, and control) and overall cardiovascular disease risk among PWH who use a safety net clinic, emphasizing the unique HTN care needs of people with severe financial challenges. Results will be immediately usable by HIV safety net clinics; they will inform HIV/HTN integrated health care delivery models and the development of future HTN interventions.

Public health relevance
PUBLIC HEALTH RELEVANCE We know that people with HIV (PWH) who experience severe financial challenges resulting in conditions like unstable housing and food insecurity have disproportionately high rates of cardiovascular comorbidities underscored by hypertension (HTN). However, similar to the HIV care cascade, there is a series of steps for achieving HTN control (the HTN care cascade). We still do not know where on the HTN cascade PWH are dropping off, or why. This study will use quantitative methods to determine the extent and predictors of the drop-off at each step of the care cascade among PWH who use a safety net clinic, and qualitative methods to understand the underlying reasons.